Senior Research Career Scientist

Overall goals: My laboratory strives to understand and facilitate the neuroinflammatory response to all implanted
devices within the central nervous system. Such devices range from ventricular shunts to various types of
stimulating and recording electrodes. However, most of my efforts have been on intracortical microelectrodes
due to their significance in research to understand the brain and the role in rehabilitative applications of Brain
Computer Interfacing, which is of particular interest to the VA. By understanding mechanism of failure, we can
pursue both materials-based and therapeutic-based methods to mitigate the inflammatory-mediated failure.
1) Role of tissue/device mechanical mismatch in microelectrode failure. We developed biologically inspired
materials for intracortical microelectrodes to independently examine and manipulate device modulus, geometry,
and drug-eluting capabilities. We have demonstrated that mechanically dynamic intracortical microelectrodes
are stiff enough to be inserted into the brain, become compliant to reduce micro-motion and inhibit late-stage
neuroinflammatory responses, can be fabricated into functional intracortical microelectrodes, and can be utilized
to deliver anti-inflammatory therapeutics from the device substrate or in combination with microfluid devices.
2) Role of oxidative stress in microelectrode failure. Oxidative pathways have been implicated in both
neurodegeneration and corrosive damage to both the metallic and insulating materials of current intracortical
microelectrode technologies. Thus, approaches to mitigate or attenuate the deleterious effects of oxidative
inflammatory products are of significant importance. We have demonstrated that several antioxidants can be
delivered systemically or locally to temporally mitigate neuronal damage and loss, and that bioactive coatings
with mimetic anti-oxidative enzymes can prolong neuroprotection and improve recording performance.
3) Role of specific immunity pathways in microelectrode failure. Pathological assessment of the
neuroinflammatory response to intracortical microelectrodes has been limited to a dozen or so known
neuroinflammatory proteins. We are using spatially resolved omics to developed one of the most comprehensive
analyses to date the microelectrode/tissue interface. By identifying genes and proteins of interest, we can then
explore hypotheses about specific innate immune systems or develop gene therapies for immune cell silencing.
4) Role of gut microbiome in microelectrode failure. Microbiome may play a role in modulating
neuroinflammation. Constituents of the gut microbiome can directly infiltrate the brain causing a local
inflammatory response, or act indirectly via metabolites or inflammatory factors that enter the blood stream and
cross the blood brain barrier. We utilized 16S rRNA analysis to show that the composition of gut-resident
microbiome in feces and brain tissue changes following microelectrode implantation and can be modulated
through treatment to impact the quality of chronic intracortical recordings. We seek to translate these findings
from preclinical to clinical therapies to improve microelectrode performance.

Public health relevance
Intracortical microelectrodes offer unparalleled specificity, resolution and accuracy for interfacing assistive technologies with the brain. Brain-Machine Interfaces allow volitional thoughts to control an external device, be it a computer cursor, a robotic arm, or one’s own muscles. The majority of research to create a reliable brain machine interface has focused on the needs of severely paralyzed or “locked-in” patients. A wide spectrum of disabled veterans, including individuals with spinal cord injury, stroke, and Amyotrophic Lateral Sclerosis (ALS, would benefit from such technology which has incredible potential to greatly improve independence and significantly enhance quality of life. Yet, the longevity of these interfaces is compromised by mechanical, biological and inflammatory processes which limits the reliability of their clinical outcomes. My research is dedicated to mitigating the factors that limit the performance of microelectrodes, and ultimately allowing them to function for longer durations, to enable clinical application to disabling neurological disorders affecting veterans.